INVESTIGATION OF CLINICAL AND HORMONAL EFFECTS OF SOMATOSTATIN ANALOGUE

This study will determine whether somatostatin analogue Sandoz 201-995 is effective in suppressing hormone secretion by aggressive hypersecretory endocrine tumors.